Measuring the Value of Improving Access to Community Care

Background: Providing timely access to health care has been a long-standing VA goal that has been re-
emphasized by the Commission on Care. To improve access to care, VA implemented the Veterans Choice
Program in August 2014, which provides eligible Veterans the option of receiving care from community
providers paid for by VA. Currently, there is a substantial gap in scientific evidence on the effect of the Choice
Program and other VA community care programs, particularly in regards to the degree the program has
improved access to care. More generally, non-VA literature examining the effect of greater provider options
has focused on changes in utilization, but has not assessed the value of improved patient choice. The
development of measures that capture the value of greater provider options is methodologically challenging
because patients’ preferences are not directly observed and value encompasses many dimensions of access
(e.g., travel distance, appointment wait times, provider quality, etc.). To address these evidence gaps, we
propose the development and examination of new measures capturing the value of provider options to
Veterans using state-of-the art econometric methods. Greater scientific evidence to help VA provide enhanced
choice for Veterans through the Choice Program and future VA community care programs is consistent with
the VHA FY 2018-2019 Operational Plan. This study addresses the ORD-wide Learning Health Care System
priority area and HSR&D’s Access and Health Care Systems Change major priority domains.
Objectives: The objectives of this study are to: 1) develop new econometric method applications to
quantitatively measure the value of greater access to providers from the perspective of Veterans and 2)
examine the relative importance of local area and provider characteristics in determining Veterans’ value of
having improved access to providers.
Methods: This observational study will examine VA administrative data and existing public data characterizing
outpatient providers. In Aim 1, we will use VA administrative data to identify: 1) Veterans eligible for the VA
Choice Program in 2016, 2) VA and Choice outpatient providers and 3) utilization of outpatient services from
VA facilities and through the Choice Program. We will analyze Veterans’ revealed preference for providers
using econometric random utility models. These models assume patients select the provider that yields the
greatest benefit, given all available options. We will empirically estimate Veterans’ choice of provider within the
random utility framework using a nested multinomial logit model (NMNL). We will then use parameter
estimates and predictive margins from the NMNL model to calculate the value of greater provider options
through the Choice Program. Specifically, econometric models will calculate Veterans’ willingness to pay
(WTP), which represents the maximum dollar amount an individual would theoretically pay for greater provider
options. In Aim 2, we will apply econometric decomposition methods to models developed in Aim 1 to assess
the influence of key provider and local area characteristics in determining value. Notably, we will leverage
novel data linkages between VA administrative data and public use data capturing an extensive set of provider
characteristics.
Statement on Next Steps: We will develop a simulation tool designed for non-researchers that incorporates
study results to estimate the value to Veterans of a specified set of provider options (i.e. a community care
network). This tool will provide the ability for operational partners to assess the adequacy of community care
networks and establish the business case of “what-if” scenarios. Stakeholders will be able to adapt to changing
conditions through simulating the hypothetical addition and subtraction of providers within a community care
network. This simulation feature will facilitate future analyses to ensure community care networks include high
quality providers that best match Veterans’ preferences.

Public health relevance
The goal of this study is to develop innovative econometric methods for measuring the value of greater provider options from the perspective of Veterans. The proposed study is timely and policy relevant in light of the Commission on Care’s top long-term recommendation for transforming VHA through the establishment of community care networks for Veterans to access high quality care. Findings from this study will help inform VA’s rapidly evolving role as a payer. Specifically, the development of value measures and the identification of provider attributes that most greatly increase value to Veterans will help VA assess the adequacy of community care networks and select contract providers to most effectively meet Veterans’ health care needs. The strategic selection of high quality provider options available through the Veterans Choice Program and future community care policies is of high interest to key operational partners including the Office of Community Care.